Novel Pharmacological Approach to Stroke Neuroprotection

Diabetic patients (Type2) are not only at a 2 to 6-fold higher risk for having acute ischemic stroke, but also suffer
from neurovascular complications, including blood-brain barrier-BBB leakage, edema and hemorrhage and poor
recovery after ischemic stroke. Despite recent advances, interventions to mitigate these risks after stroke are
high research priority. Disruption in normal calcium homeostasis is a major initiator and contributor to diabetes
induced ischemic brain injury. SERCA2 (sarco/endoplasmic reticulum Ca2+ ATPase pump) is an important
regulator of intracellular Ca2+ concentration. Diabetes and stroke reduce SERCA2 expression and function,
increase cytosolic Ca2+ concentration, and subsequently enhance cell death and tissue damage associated with
endoplasmic reticulum (ER) stress, mitochondrial dysfunction, inflammation, and oxidative stress. Thus,
targeting dysfunctional SERCA2 could be a potential therapeutic opportunity to alleviate neurovascular
complications associated with diabetes in stroke. In this proposal we will investigate the beneficial effect and the
mechanisms of our newly developed small molecular SERCA2 activator CDN1163 for treating neurovascular
complications associated with diabetes comorbidity in stroke. Our preliminary data show diabetic (Ob/ob) and
wild-type (WT) mice have lower SERCA2 expression after stroke, while treatment with CDN1163 reduced infarct
volume and functional deficits after stroke. Based on our solid scientific publications and compelling preliminary
observations, our central hypothesis is that SERCA2 activation after stroke will restore diabetes associated Ca2+
dysregulation and attenuate ER stress, mitochondrial dysfunction, and, subsequently, neurovascular, and
functional recovery. Using comprehensive, novel approaches with state-of-the-art in vivo and in vitro, models,
molecular biological, approaches, including comprehensive single-cell RNAseq transcriptional regulation, this
project explores the underlying cellular and molecular mechanisms driving CDN neuroprotection in diabetic
stroke injury.

Public health relevance
Diabetes is an independent risk factor that promotes neurovascular dysfunction and increases the occurrence and poor recovery after ischemic stroke. Data from animal studies demonstrate that intracellular calcium dysregulation in brain cells due to a defect in an enzyme that controls the level of calcium contribute to the development of stroke. We have identified a drug that normalizes intracellular calcium and protects against diabetes induced stroke injury.